OPERATION & SUPPORT OF THE CTEP PROTOCOL AND INFORMATION OFFICE (PIO)

The Protocol Information Office (PIO), Cancer Therapy Evaluation Program (CTEP), Division of Cancer Treatment and Diagnosis (DCTD), National Cancer Institute (NCI) is responsible for the receipt and facilitating review of documents used in the majority of NCI sponsored treatment and non-treatment trials. The purpose of this contract is to provide support of CTEP functions, mainly in support of protocol related reviews (e.g., all processes surrounding tracking reviews and distributing review outcomes – database abstraction, recording decisions, supporting review meetings and conference calls, consolidating reviews, distributing outcome letters), distributing adverse event reports to lead protocol organizations, tracking Operational Efficiancy Working Group (OEWG) timelines, as well as maintaining an email box for protocol related inquiries.